PD-L1 MODIFICATIONS IN CANCER DIAGNOSIS AND TREATMENT

PD-L1 Modifications in Cancer Diagnosis and Treatment
PROJECT SUMMARY
Programmed death ligand 1 (PD-L1, also known as CD274 or B7-H1) is the principal ligand of programmed
death 1 (PD-1), a coinhibitory receptor on activated T cells. In the tumor microenvironment, PD-L1
overexpression is an immune evasion mechanism exploited by tumor cells and is generally associated with a
poor prognosis in cancer patients before the era of immunotherapy. PD-L1 is a type I transmembrane protein
with immunoglobulin V-like and C-like structures in its extracellular domain. Interaction between PD-L1 and
PD-1 is a key oncogenic process between tumors and the host system. Inhibiting antibodies to block PD-1 or
PD-L1 has revolutionized cancer care, whereas PD-L1 detection is often used as a companion or
complementary diagnostic biomarker. However, contradictory evidence exists as to its role across histotypes.
PD-L1 detection in tumors is complex because of variable antibodies and platforms, the subjective nature of
scoring, and non-interchangeable definitions of PD-L1 positivity. Our preliminary studies demonstrate that a E3
ligase mediates non-proteolytic ubiquitination of PD-L1, facilitating its translocation from the cytosol to the
plasma membrane, where it binds PD-1 extrinsically to prevent tumor cell killing by T cells. In this application,
we propose two specific aims to ascertain the pathobiological role and translational significance of the non-
proteolytic ubiquitination of PD-L1 in evading tumoricidal T cells and cancer care using lung cancer as a model.
Lung cancer is chosen because it causes over 100,000 deaths annually in the United States and most FDA-
approved anti-PD-L1 or anti-PD-1 treatment antibodies can be used for lung cancer. More lung cancer patients
benefit from immune checkpoint blockade (ICB) than patients with any other cancer type. ICB therapies are
usually recommended for late-stage lung cancer. However, most lung cancer patients do not respond to ICB
therapy. Aim 1 will evaluate the clinical significance of PD-L1 and the E3 ligase expression in lung cancer
diagnosis and prognosis. Aim 2 will dissect the molecular mechanisms of PD-L1 protein modifications in
immune suppression using lung cancer cells and mice. This project will reveal the interplay among
ubiquitinated PD-L1, the E3 ligase, anti-PD-L1 antibodies, and PD-1, which represents critical tumor and
immune cell interactions in the tumor microenvironment to promote or attenuate tumorigenesis and
progression. We expect to provide new insights into the molecular regulation of PD-L1 endomembrane
trafficking and the clinical values of membranous PD-L1 and the modifying enzyme for lung cancer diagnosis,
prognosis, and treatment.

Public health relevance
PROJECT NARRATIVE PD-L1 is overexpressed in many types of tumors and contributes to the inhibition of effective antitumor immunity. We will use a variety of approaches to determine the pathobiological significance of PD-L1 protein modifications in cells, mice, and human tissues. This work will build a solid scientific foundation to bring checkpoint inhibition to more cancer patients.